Signaling through intestinal MUC receptors by bacterial Serine Proteases of Enterobacteriaceae

Abstract
Both, Enteroaggregative Escherichia coli (EAEC) and Adherent-Invasive E. coli (AIEC) are associated with
clinical and subclinical inflammation. EAEC is an important pathogen of traveler's diarrhea, diarrhea in
industrialized countries and growth faltering in developing countries. Clinical findings suggest that the host
inflammatory responses play a substantial role in EAEC pathology given that elevated levels of pro-
inflammatory markers, including interleukin (IL)-8, IL-1β, fecal lactoferrin and leukocyte infiltrates are often
found in EAEC-infected individuals. Most importantly, even asymptomatic patients infected with EAEC were
found to exhibit growth retardation and intestinal inflammation. On the other hand, AIEC has been implicated in
the pathogenesis of the Inflammatory Bowel Disease (IBD) and it is often found adhered to the inflamed
intestinal mucosa. Persistent infection with AIEC leads to chronic inflammation and intestinal fibrosis.
Nevertheless, the culprits associated with the inflammatory response during infection with these pathogens are
not entirely understood. Increasing evidence suggests that bacterial luminal protease activity and activation of
protease receptors ultimately results in increased intestinal permeability and exacerbation of colitis in animal
models and in human. In this regard, our data suggest that proteases belonging to the serine protease
autotransporter of Enterobacteriaceae (SPATEs) family are associated with inflammatory processes by binding
and cleaving transmembrane signaling mucins (MUC). Our overall hypothesis is that SPATEs with mucinolytic
activity trigger intestinal inflammation by targeting intestinal MUC receptors during bacterial infections.
This project is comprised by three specific Aims. In Aim 1, we will characterize the signaling pathways
activated by C2S through intestinal MUC receptors using human colonoids. In Aim 2, we will investigate if
mammalian lectin, sheddases and SPATEs use the same mechanism to activate MUC receptors and if they
trigger similar signaling pathways. In Aim 3, we will investigate the role of SPATEs in the pathogenesis of
EAEC and AIEC in the context of MUC receptor signaling. We will leverage the experimental systems and
collaborations developed under current projects to take this understanding to an actionable level and identify
promising lead interventions.

Public health relevance
PROJECT NARRATIVE The serine protease autotransporters of Enterobacteriaceae (SPATEs) constitute a superfamily of secreted virulence factors produced by pathogenic E. coli strains, Shigella and Citrobacter species, all agents of enteric/diarrheal disease. This project investigates the role of SPATEs in intestinal inflammation by signaling through transmembrane MUC receptors in the human intestine, and proposes to identify the signaling pathways, mechanism of MUC receptor activation and its relevance in bacterial pathogenesis. Our findings will greatly advance our understanding of SPATE's roles in intestinal inflammation and potentially could identify promising lead interventions.